CONGENITAL THROMBOTIC DISEASE IN PEDIATRICS

Children with congenital thrombotic disorder including deficiencies of AT- III, protein C and protein S will be evaluated with detailed functional and structural analysis of the deficient of defective protein. Where clinically indicated, therapeutic trials will be conducted.